Dyadic Neurofeedback for Development of Healthy Emotion Regulation in Youth

PROJECT SUMMARY
Adolescents with a family history of adverse childhood experiences (ACEs) are at heightened risk for
depression and other mental health problems related to poor emotion regulation (ER). Parents play a crucial
role in adolescents’ development of ER skills, and parenting practices are related to the structure and function
of adolescent brain regions underlying emotion reactivity and regulation. Parenting has yet to be utilized,
however, to directly modulate adolescent ER neurocircuitry in order to promote adaptive ER development. The
proposed study will test the efficacy of a real-time fMRI dyadic neurofeedback (DNF) protocol to promote
healthy ER-related neurodevelopment in female adolescents with a maternal history of ACEs. The proposed
study will use DNF to provide neurofeedback from the adolescent’s anterior insular cortex (aIC) to the
adolescent’s mother as the mother and adolescent engage in an emotion discussion task together. Parents
and adolescents (n=35 active DNF; n=35 control) will communicate via microphones and noise-canceling
headphones while the adolescent is undergoing fMRI scanning. Specific aims of the current study are to
determine: 1) the effects of aIC DNF on the developing ER network in adolescents with a history of maternal
ACEs, 2) associations between parenting practices during DNF and reduced adolescent aIC activation, and 3)
longitudinal effects of aIC DNF on adolescent internalizing symptoms. This study is significant because
engaging with parents in DNF can promote positive ER development in at-risk adolescents. Adolescence is a
sensitive period for the development of ER, and adaptive changes in neurocircuitry and the parent-adolescent
relationship could promote resilience to later mental health problems. This study is innovative in that DNF is a
novel neurobehavioral approach with the potential to simultaneously affect both parenting behavior and
adolescent neurobiology. The study employs an experimental paradigm with naturalistic aspects that are often
lacking in fMRI studies, thus increasing the generalizability of DNF effects outside the scanner. The overall
impact of the proposed study will be the evaluation of a novel neurobehavioral approach to the promotion of
adaptive ER skills in adolescents that can inform future prevention and intervention efforts for psychiatric
disorders, including cost effective and community-based applications, aimed at preventing the
intergenerational effects of ACEs on mental health.

Public health relevance
PROJECT NARRATIVE Adolescent mental health problems increasingly constitute a major public health threat, with depression and suicidality rising at alarming rates in recent decades. The proposed project seeks to address a key risk factor for such problems – emotion dysregulation – by leveraging parental influences on adolescent emotion regulation through the use of a novel neurobehavioral paradigm for at-risk adolescents. Knowledge gained from this project and related future directions will enhance the lives of adolescents by improving our understanding of how parenting can be used to affect brain development to promote positive socioemotional outcomes.